Investigation of the endogenous opioid neural circuitry in pain

PROJECT SUMMARY
The opioid epidemic has encouraged the biomedical research community to explore new pain
targets and further study opioid’s most famous target, the mu opioid receptor. One underexplored
arena is the study of the endogenous opioid peptide system, which we know very little especially
in comparison to our knowledge of the receptors they activate. This is despite the commonsense
understanding that the endogenous peptides must change as a result of the allostatic load
imposed by chronic pain, opioids, and chronic opioid exposure. There are well established sex
differences in the actions of opioids at the mu opioid receptor, but it is unknown whether there are
also differences in the endogenous opioid peptides. The experiments outlined here lay the
necessary and long overdue groundwork to understand the neural mechanisms of one class of
the endogenous opioids, called enkephalins, and how they contribute to pain. In the first aim, we
will quantify enkephalin mRNA expression in regions of the brain known to play a role in top-down
pain modulation. Next, we will use a viral retrograde tracer to map the enkephalin containing
neurons that synapse in the PAG, something that has never been done before. In Aim 2 we will
probe the behavioral effects of activating enkephalin containing neurons that synapse in the PAG
using excitatory and inhibitory chemogenetic approaches followed by assessment on pain assays.
We expect that increasing activation of all enkephalin neurons that synapse in the PAG will result
in increased antinociception. Further, we expect that inhibition will lower the endogenous opioid
release and therefore produce pain. We will further isolate certain neural projections from one
brain region at a time to elucidate which brain regions are driving the enkephalin mediated
antinociceptive responses. This research will allow us to better understand how the endogenous
opioid system facilitates pain control and whether there are underlying differences that lead to
differences in pain modulation in males and females.

Public health relevance
PROJECT NARRATIVE As we continue to fight to understand the opioid epidemic and a chronic pain crisis, a major avenue of research has remained glaringly under-investigated: the role of endogenous opioid peptides. This study will lay the long-overdue groundwork into investigating the role that the endogenous opioids play in mediating pain and the role they play in the sex differences that exist in pain and opioid analgesia.